Path C Montana Department of Agriculture Produce Safety Education, Outreach, Compliance, and Enforcement of the FSMA Produce Safety Rule - PATH C

Project Summary/Abstract
The Montana Produce Safety Program’s mission is to build a collaborative infrastructure to
support Produce Safety Rule compliance training, education, outreach, technical assistance, and
enforcement as it relates to Montana’s produce industry. As we continue in our efforts to carry
out the components of our program’s mission, the impact will be safer produce and fewer
associated foodborne illness outbreaks across Montana and beyond.
Additionally, we are providing the following required information for this section:
a) The Montana Produce Safety Program is applying in Program Path C for The FDA's Cooperative
Agreement Program for States and Territories to Implement a National Produce Safety Program
PAR-21- 174
b) The Montana Produce Safety Program does not intend to conduct sprout inspections under
Subpart M of the Produce Safety Rule.
c) Montana state law confirming inspection and enforcement authority:
https://leg.mt.gov/bills/mca/title_0800/chapter_0030/part_0030/section_0030/0800-0030-
0030-0030.html
The Montana Produce Safety Program confirms that we have obtained adequate inspection and
enforcement authority by adopting the FDA Produce Safety Rule in its entirety, by reference.

Public health relevance
The objective of the Montana Produce Safety Program project is to align itself with the Produce Safety Rule and implement the standards of the rule, while also providing outreach and technical assistance to growers. Such alignment will advance the overarching goal of decreasing the number of foodborne illnesses and outbreaks associated with fresh produce.